CRCNS Research Proposal: Collaborative Research: Neural Basis of Motor Expertise

How can a basketball player reliably land his free throw in the basket, and yet still miss occasionally under
nominally identical circumstances? While such skills are a paragon of motor expertise, even seemingly
mundane actions also require surprising dexterity. When carrying a full cup of coffee, we exhibit motor
skill that is far beyond what is typically studied in the laboratory. Specifically, when interacting with objects
- the essence of any tool use -, successful actions require fine-grained control of interaction forces that
have been beyond the purview of neuroscience to date. The proposed research examines the neural
basis of motor expertise by bringing rich interactive tasks into the laboratory. The two PIs combine their
long-standing experience in computational motor control and neurophysiology to study novel behavioral
paradigms both in humans and non-human primates. Building on conceptual and computational overlap in
their respective research, where skill is associated with low-dimensional structure in high-dimensional
neural and behavioral redundant spaces, they will test the overall hypothesis that patterns of neural
activity exhibit many of the characteristics of the behavior. Two aims will study two examples of motor
skill: throwing an object and transporting an object with internal dynamics, both rendered in virtual
environments. Parallel experiments in humans and primates will generate rich behavioral data that will be
matched with intracortical recordings in the cerebral cortex of non-human primates. To date, non-human
primate studies have necessitated that animals perform near-identical repetitions of simple behaviors to
facilitate the analysis of neural activity. Now, modern multi-neuronal recording techniques make it possible
to embrace more sophisticated real-world behaviors and address core principles of movement discovered
in human motor control: high dimensionality, redundancy, and the ever-present variability. This research
will develop a suite of computational tools that afford the analysis of behavioral and neural data with
commensurate techniques and sophistication. This research will be transformative as it advances the
motor challenges examined and brings insights from intracortical neurophysiology closer to understanding
of human motor expertise. These scientific insights will channel into a large range of outreach activities to
achieve broader impacts for the general public.
RELEVANCE (See instructions):
Patients with neurological disorders such as stroke face challenges in their daily activities, grasping a cup
to bring to their mouths to drink; these actions are essentially interactive tool use. This research seeks
insights into neural activation during such skilled actions and interactions to get closer to understand
neural activity in tasks relevant in real life. Extending from PI Batista’s experience, neuroprosthetics and
brain-machine interfaces are direct clinical application that may benefit from our findings and recovery